EXPAND LN2 PIPING DISTRIBUTION, WEDGEWOOD SUITE K

This project will expand the LN2 freezer capacity at Wedgewood Suite K to add 86 LN2 freezers. This project is necessary because the NCI at Frederick Central Repository is reaching LN2 freezer capacity. The additional LN2 drops will supply LN2 to the growing number of LN2 and Vario, LN2-fueled freezers.